Combining Targeted Demethylation with Noncoding RNA-mediated mRNA Stabilization as a Strategy for Therapeutic Arteriogenesis in the Aged

ABSTRACT:
Aging and age-related diseases like peripheral artery disease (PAD) lead to considerable morbidity and
mortality. Aging is associated with impaired inflammatory arteriogenesis responses to injury. We defined a
macrophage signaling axis that activates the mRNA stabilizing protein, HuR, to promote VEGF-A expression
required for arteriogenesis. We seek to understand the effects of aging on this pathway. Moderately aged (52-
week-old) mice demonstrated reduced blood flow recovery and decreased arteriogenesis relative to young (12-
week-old) mice in a femoral artery ligation model of ischemia. In aged mice, ischemic muscle tissue and
macrophages revealed reduced VEGF-A expression. Aged macrophages demonstrated increased global DNA
methylation, and though macrophage HuR expression was normal, there was reduced HuR binding to VEGF-A
mRNA with consequent shortened VEGF-A mRNA half-life. Somewhat surprisingly, Dicer1, previously
established as destabilizing for VEGF-A mRNA, was downregulated in aged macrophages. The DNMT
inhibitor, RG108, led to increased Dicer1 and VEGF-A expression and increased HuR binding to VEGF-A
mRNA. miR-29, as a 3p miRNA, appears to be particularly sensitive to changes in Dicer1 expression. Aged
macrophages had decreased expression of miR-29, whose seeding site in the 3′-UTR of VEGF-A is adjacent
to the HuR binding site. Transfection of macrophages with miR-29 mimic increased VEGF-A expression.
Myeloid Dicer1-deleted mice were phenotypically similar to aged mice, having decreased blood flow recovery,
decreased VEGF-A expression, and decreased HuR binding to VEGF-A mRNA with consequent shortened
mRNA half-life. Our hypothesis is that aging acquired methylation of Dicer1 with consequent reductions in
Dicer1 dose-sensitive microRNAs (i.e. miR-29-3p) results in reduced binding of HuR to VEGF-A mRNA and
reductions in both VEGF-A expression and consequent VEGF-A dependent angio/ arteriogenesis. Our aims
seek to 1) define Dicer1 promoter methylation in aged mice to be a major mechanism of impaired VEGF-A-
mediated arteriogenesis with aging; and 2) define the molecular mechanisms whereby the Dicer1 dose-
sensitive microRNA, miR-29-3p, promotes HuR-binding to VEGF-A mRNA with consequent message
stabilization. Our studies will lead to a paradigm shift from Dicer1 as a negative regulator of VEGF-A to that of
a positive regulator. The rescue of macrophage VEGF-A expression by demethylation of Dicer1 or noncoding
RNA (i.e. miR-29) mimics, may have profound implications in the development of treatment strategies that can
promote arteriogenesis and associated tissue preservation in the setting of severe age-related vasculopathies.

Public health relevance
PROJECT NARRATIVE: As people get older, they lose the ability to grow new blood vessels to help with healing particularly as cholesterol builds up in the blood vessels throughout the body. Our blood cells have the ability to activate the growth of new blood vessels, but the pathways involved and the impact of aging on this ability are not fully understood. This grant seeks to understand the age-acquired changes in certain genes that might influence the signals required for new blood vessel growth. This study will lead to new medicines that can improve blood vessel growth where needed for more rapid healing in older patients.